Mayo Clinic - To enable the Native CIRCLE to obtain cancer control r

THIS PROJECT SEEKS TO ESTABLISH THE BASE PERIOD TO ENABLE THE NATIVE CIRCLE TO OBTAIN CANCER CONTROL RESEARCH AND EDUCATIONAL MATERIALS FOR RESEARCHERS.